A Text-Based Adherence Game for Young People Living with HIV in Ghana

PROJECT SUMMARY
Maintaining adherence to HIV treatment is a challenge and nonadherence is associated with heightened risks
for secondary HIV transmission and poor health outcomes. In sub-Saharan Africa, an estimated one in three
patients do not take antiretroviral therapy (ART) as prescribed and one in four disengage from treatment
within a year of initiating ART. Adherence to care outcomes are even worse among older adolescents and
young adults (young people) living with HIV (YPLH) who experience the highest rates of ART nonadherence,
treatment attrition, and virologic failure compared to other age groups. Consistent with the Division of AIDS
Research’s areas of High Priority, the current project targets YPLH using a novel mHealth gaming intervention
in order to promote their adherence to HIV care. Candidate: The candidate is a clinical scientist with a
background in clinical and community psychology. His prior research focuses on the development of
interventions to prevent HIV infection among underserved youth, primarily in the United States (U.S.). He is
applying for a five-year K23 Career Development Award in order to expand his expertise and support his
training, mentorship, and research within a novel area of intervention in a sub-Sahara African country
(Ghana). Mentoring: Six well-established researchers serve as mentors on this proposal. Each brings
complimentary expertise consistent with the study’s aims and training objectives. Dr. Larry Brown is the
Primary Mentor and has experience in creating mobile gaming interventions for YPLH in the U.S. Four other
mentors are HIV-focused investigators with expertise in global health research (Dr. Matthew Mimiaga), studies
in Ghana (Drs. Awewura Kwara and Margaret Lartey), and applied qualitative methods (Dr. Kate Guthrie). Dr.
Beth Bock is an expert in mHealth interventions including the use of text messages to address substance use.
Research: The aims of the proposed project are to (1) gather information on the barriers and facilitators to
adherence to care among YPLH attending an HIV clinic in Ghana and gauge YPLH preferences for an mHealth
intervention via in-depth interviews with YPLH , their treatment buddies, and clinic staff; (2) develop a Text-
Based Adherence Game to promote adherence to care by consulting with an mHealth developer and conducting
an iterative open trial of the intervention with YPLH (n = 24); and (3) evaluate the intervention for feasibility
and preliminary efficacy with a small randomized pilot examining biobehavioral adherence outcomes over one
year in a sample of YPLH who receive the Text-Based Adherence Game versus YPLH who receive the standard
of care (n = 60). Training: Specific training overseen by the mentorship team through formal coursework,
workshops, seminars, conferences, directed readings, clinical work, and mentored experiences will be received
by the candidate. Areas of focus include HIV-focused research in sub-Saharan Africa, broadly, and in Ghana,
specifically; methodological and technical mHealth skills; and knowledge of gamification. The candidate is
institutionally supported by Rhode Island Hospital and the Alpert Medical School of Brown University.

Public health relevance
PROJECT NARRATIVE Maintaining lifelong adherence to HIV care is a major challenge for young people living with HIV in resource- limited areas of sub-Saharan Africa where HIV infection is globally most prevalent. Innovative, low cost, and easily scaled strategies are urgently needed to improve young people’s engagement to HIV treatment and reduce the public health consequences associated with nonadherence including secondary transmission of HIV infection. The current study addresses this concern by testing a novel mobile health intervention that uses text messages and gamification of adherence behavior to improve adherence to care outcomes among young people living with HIV in Ghana.